VENTILATORY ASSISTANCE DURING SLEEP IN COPD PATIENTS WITH HYPERCAPNIA

To study the clinical efficacy of nocturnal nasal ventilation (NNV) for the treatment of COPD patients with hypercapnic respiratory failure.